Multi-Task MR Simulation for Abdominal Radiation Treatment Planning

ABSTRACT The accuracy of radiation treatment planning (RTP) heavily influences the effectiveness of external beam radiotherapy (EBRT). Individualized RTP begins with a “simulation”, in which the patient in a treatment position is commonly scanned using computed tomography (CT) to define the treatment target and organs at risk (OARs). When soft-tissue contrast is inadequate to support accurate target and OAR delineation in CT based RTP, conservatively large treatment margins are used to avoid a geometric miss. The crude treatment prevents delivering sufficient radiation dose to the tumor without exceeding the tolerance of surrounding normal tissues. Magnetic resonance (MR) can be used as a simulation platform complementary to CT for improved soft-tissue conspicuity. Yet, such a complicated, costly and tedious multi-modal RTP workflow along with unavoidable systematic MR-CT co-registration errors has limited its applications in EBRT, especially at the abdominal site whereby anatomies are highly mobile. Over the past few years, there is a keen interest in the integration of MR alone into RTP and even the therapy workflow (i.e. MR-guided radiotherapy, MRgRT). The abdomen poses critical challenges to MR simulation. Current MR imaging sequences are suboptimal to produce motion-free images and resolve respiratory motion. MR data processing for abdominal RTP is underdeveloped. Contouring of OARs typically relies on manual, tedious procedures that are time-consuming and variation-prone. In this proposal, we will substantially improve the MR acquisition and multi-organ auto-segmentation, so the potential of MR as a simulation modality can be fully unleashed for abdominal EBRT. Three specific aims will be completed. In Aim 1, we will develop a standalone multi-task MR (MT-MR) sequence dedicated to abdominal MR simulation. In Aim 2, we will optimize multi-organ auto-segmentation based on MT-MR images. In Aim 3, we will assess the performance of MT-MR in the context of pancreatic cancer stereotactic body radiotherapy planning. Successful completion of the project will dramatically improve treatment precision and clinical outcomes, thus further promoting the adoption of radiotherapy in the management of abdominal cancers. Moreover, the developed techniques will open the door to future studies aiming at optimizations in many aspects of radiotherapy.

Public health relevance
PROJECT NARRATIVE Imaging is essential for precise radiation treatment planning. MR based planning is challenging in the abdomen whereby anatomies are highly mobile. We will substantially improve the MR acquisition and multi-organ auto- segmentation, so the potential of MR as an imaging-based planning modality can be fully unleashed for abdominal radiation treatment.